Health and Financial Costs of Unequal Care: Colorectal Cancer as a Case Study

ABSTRACT
There is increasing awareness of systematic racism in US health care. Clinical algorithms that include race,
which are often incorporated into electronic health systems meant to facilitate guideline care, are a striking
example of overt and systemic differences in recommended care. Differences in care and reasons for these
differences are often more difficult to identify and address. Colorectal cancer (CRC) care provides a case
study. There is ample evidence of racial disparities in every step of the colorectal cancer care continuum, from
early detection to treatment, especially for differences between Black patients and White patients. Compared
to White people, Black people are less likely to be screened for CRC, less likely to receive endoscopic tests at
high-quality facilities, more likely to be diagnosed at a later stage, less likely to receive curative treatment –
even after accounting for stage at diagnosis, and have 40% higher mortality and shorter stage-specific survival.
These differences in care have both health and economic consequences. In addition to worse outcomes, Black
people have higher CRC-attributable treatment costs. We propose to extend and apply CRC-SPIN, an
established microsimulation model for CRC, to synthesize the available evidence related to racial and ethnic
differences in CRC risk, CRC care, and costs of care. We will extend CRC-SPIN, which currently simulates the
overall US population, to simulate the natural history of CRC among specific racial and ethnic groups
represented in SEER data (American Indian/Alaska Native, Asian or Pacific Islander, Black, White and
Hispanic/non-Hispanic). Extension of CRC-SPIN to include race/ethnicity will focus on incorporating available
information about differences in CRC risk. We will also extend CRC-SPIN to simulate patient characteristics
beyond race/ethnicity that are related to screening, such as insurance status, which mediate the relationship
between race/ethnicity and CRC care. We will use the resulting model to simulate the overall impact of
disparate care on CRC outcomes, and to identify elements of the care process that have the largest impact on
outcomes to better guide health policy. Health outcomes will include life years lost, disease-free life years lost,
excess CRC, and excess late-stage CRC. Financial outcomes will assess societal costs, including screening
costs, treatment costs and lost income both overall and for specific racial/ethnic groups. We will use robust
decision making approaches to address uncertainty in the differential risk of CRC and differential CRC care.
We will use the model to project the impact of policy scenarios designed to reduce racial/ethnic disparities in
CRC to assist in identify the most effective policy scenarios for reducing racial/ethnic disparities in CRC.

Public health relevance
PROJECT NARRATIVE Colorectal cancer (CRC) is the third most common cancer and the third leading cause of cancer death, but it affects some racial and ethnic groups more than others. Our proposed research will summarize current knowledge about racial/ethnic disparities in CRC screening, treatment, and outcomes, and will use this information to estimate the extent to which disparities in care explain disparities in CRC outcomes, and to evaluate policies to reduce disparities.